Enabling translation of cancer cell proliferation PET imaging via droplet radiochemistry technology

PROJECT SUMMARY
Despite the widespread use and success of [18F]FDG-PET imaging in oncology, there are many situations where
[18F]FDG cannot be used for diagnosis or treatment monitoring, especially for cancers where there is high
background uptake, low tissue density, or slow-growing tumors. Infection or inflammation frequently leads to
false positives. Many tracers are being developed that provide improved contrast, sensitivity, and accuracy
compared to [18F]FDG. Of particular interest is the nucleoside analog [18F]FMAU, which is incorporated into DNA
when tumor cells divide, thus directly measuring increased cell proliferation, a universal hallmark of cancer.
Promising clinical data of [11C]FMAU and preclinical data of [18F]FMAU have led to initial clinical studies of
[18F]FMAU in cancer patients, and there is high interest in clinical studies of [18F]FMAU PET as a means to
assess treatment response in diverse cancer types. However, the radiosynthesis of [18F]FMAU is very
challenging, hindering translational efforts such as multicenter clinical trials that are needed to ensure sufficient
recruitment of patient populations. Over many years, Dr. Chen’s lab at USC has improved the [18F]FMAU
synthesis using a 1-pot process, but it still involves lengthy reaction steps (~3 h synthesis), uses corrosive and
unstable reagents that are not compatible with automated synthesis modules, and has a relatively low activity
yield (~5%), making adoption of this approach extremely difficult. To widely enable clinical studies, this proposal
leverages an innovative droplet-radiochemistry approach developed in Dr. van Dam’s lab at UCLA, and now
being commercialized by DropletPharm, in which reactions are performed in 10 µL volumes instead of 1 mL
volumes, enabling higher isotope concentration, higher reaction yields and much shorter synthesis time. A
preliminary study showed [18F]FMAU could be produced in <1 h. Our central hypotheses in this project are that
cell proliferation imaging can provide a superior assessment of treatment response (e.g. earlier response
detection and higher specificity to tumor growth) than other tracers, and that droplet technology can facilitate
widespread access to [18F]FMAU for clinical translation. Leveraging synergistic academic and industry expertise
and capabilities, our multi-PI team will advance the clinical translation of [18F]FMAU via four complementary
aims: (1) Develop an optimized droplet radiosynthesis of [18F]FMAU at multi-dose scale; (2) Customize a droplet
radiosynthesizer for [18F]FMAU production, then automate and validate the synthesis; (3) Pursue preclinical
studies to evaluate [18F]FMAU for assessing treatment response (compared to [18F]FDG and [18F]FLT) to support
future clinical trials; (4) Enable wide availability of [18F]FMAU by providing a low-cost self-shielded synthesizer,
developing reagent/consumable kits, establishing a user training program, and compiling an IND amendment
that can be referenced in future trials. We believe that quantitative [18F]FMAU-PET imaging will provide early
and accurate assessment of cancer treatment leading to individually tailored therapeutic plans with improved
patient outcomes.

Public health relevance
PROJECT NARRATIVES This project aims to translate a new cancer imaging biomarker of cell proliferation ([18F]FMAU) to the clinic. This biomarker could provide high-accuracy assessment of tumor response to treatment, improving the care of cancer patients, better guiding therapy selection (when multiple options are available), and providing a powerful research tool for discovery and development of new cancer treatments. Through a synergistic academic- industrial partnership, the overall goal of this project is to make this biomarker more widely available via novel droplet radiochemistry technology and to set the stage to enable wide clinical studies.